Colaboración Evita: Cervical Cancer Prevention Partnership Center

PROJECT SUMMARY/ABSTRACT
In the Year 6 Extension (8/1/25-7/31/26), the Colaboración Evita (CE) Partnership Center will complete two
trials, ULACNet 301 and 302, at clinical sites in four Latin American countries: Peru, Brazil, Haiti, and the
Dominican Republic (DR). ULACNet 301 and 302 will use the support provided by this supplement to finish
data collection, perform assays, assemble datasets, analyze findings for publication in manuscripts and
disseminate important study results to stakeholders.
The ULACNet Trials 301 and 302 are focused on two approaches for improving HPV cancer prevention: Trial
301 focuses on vaccination and Trial 302 on screening. Trial 301 investigates several dosing regimens of the
9-valent HPV vaccine in children living with HIV (CLWH) in Peru, Brazil and Haiti, with specific focus on HPV16
and HPV18 responses after 3 vs 2 doses in CLWH and on responses after a single dose in children with vs
without HIV. Trial 302 will evaluate whether there is compelling evidence to support changing cervical cancer
screening from cytology to HPV testing for primary screening in the DR, where cytology has long been the
standard of care. It is especially key to show results directly comparing cytology to HPV testing for women with
HIV and to compare new algorithms for triage of HPV positive women by molecular assays. Trials 301 and 302
will provide evidence to inform clinical practice relating to primary and secondary prevention of HPV infection
and HPV-related disease in people living with HIV. In this year 6 extension, both trials will continue follow-up of
enrolled participants with emphasis on retention of participants and completion of all participant data collection.
Data analysis, and preparation of presentations, publications, and dissemination of trial results will be a priority
during this final year.

Public health relevance
PROJECT NARRATIVE Colaboración Evita (CE) is a Partnership Center in the US-Latin American-HPV/HIV-Cancer Prevention Clinical Trials Network (ULACNet) that will provide key evidence to reduce HPV cancers among persons living with HIV. Two CE trials will be completed during the year 6 extension period: ULACNet Trial 301 will use a precise study design to compare the immune response to different HPV vaccine (Gardasil-9, Merck) dosing regimens among children living with HIV in Peru, Brazil, and Haiti; ULACNet Trial 302 will compare primary-screen-and- triage approaches to detect the optimal strategy for cervical precancer detection among women living with HIV in the Dominican Republic.